Modulation of the tumor microenvironment with probiotic therapies

Recent advances in cancer immunotherapy have provided promising treatment options for patients with triple-negative
breast cancer (TNBC). Despite overall success in treating these malignancies, immunotherapeutic approaches
face a number of unique challenges: (1) dose limitation due to off-target side effects, (2) additive toxicity
of combination therapies, (3) and relatively low immunogenicity of breast cancer. To overcome these limitations,
this proposal seeks to engineer probiotic strains of bacteria that selectively colonize breast cancer and locally
release immunotherapeutics. The ultimate goal is to elicit more robust and diversified antitumor T cell immunity
and promote the clearance of colonized primary and metastatic breast cancer lesions and systemically growing
breast cancer-derived foci. The accompanying project will first focus on deciphering mechanisms that define the
intratumoral tropism of the probiotic strain E. coli Nissle 1917 (EcN) by using antibody-mediated depletion approaches
and targeted genetic knockouts to pinpoint host immunological pathways that regulate tumor-specific
growth. Using synthetic biology approaches, EcN will then be engineered to stably express and release checkpoint
inhibitor nanobodies targeting CD47, PD-L1, and CTLA-4 locally inside of tumors. Pro-inflammatory cytokines
will additionally be expressed to promote antigen presentation and enhance cytotoxic T cell responses.
The primary innovations of this proposal are in the combined approach of both developing a better understanding
of probiotic colonization of tumors, along with engineering probiotics as an immunotherapeutic delivery vector.
Specifically, this approach has several advantages over current therapeutic strategies, including: (1) identification
of novel EcN host strains and mechanistic understanding of their tumor colonization for further improvements
in engineered therapies, (2) tumor-specific production of immunotherapeutics, (3) bacteria lysis that leads to
effective release of novel immunotherapeutics and lipopolysaccharides (LPS) adjuvant, and (4) local delivery of
novel immunotherapeutic combinations that are toxic to deliver systemically. This work seeks to overcome current
limitations of immunotherapies, by providing a targeted vehicle to locally deliver immunotherapies that stimulate
antitumor immunity while preventing systemic toxicity and mitigating immune-related adverse effects.

Public health relevance
PROJECT NARRATIVE The engineering of tumor-specific bacteria is a transformative approach to cancer therapy, since bacteria can be genetically programmed to sense and respond to environments and locally release therapeutics. This proposal seeks to understand and engineer immunotherapeutic probiotic bacteria in the context of triple-negative breast cancer. The objective is to create a targeted therapy that locally delivers checkpoint inhibitors and cytokines to primary tumors and associated metastases, and stimulates systemic antitumor immunity with minimal side effects.